Optimizing the Diagnostic Strategy for Acute Musculoskeletal Infections in Children: Evaluating the Clinical Performance and Comparative Cost of a Noninvasive Diagnostic Technique

PROJECT SUMMARY/ABSTRACT
Pediatric musculoskeletal infections (MSKIs) are burdensome disorders that consume significant hospital re-
sources and require prompt antimicrobial treatment to prevent systemic morbidity and life-altering disability.
Identifying the causative bacterial culprit for MSKIs improves care by quickly targeting therapy. However, many
children suffering from MSKIs never have their bacterial cause identified using existing microbiological tech-
niques. Blood cultures are minimally invasive and inexpensive but only find the pathogen in 30-50% of MSKIs.
Surgically-collected biopsies of infected musculoskeletal specimens (i.e., “source cultures”) increase diagnostic
yield by 30% but require invasive and expensive diagnostic procedures with potential harm from sedation and
surgery. Studies are needed to identify the optimal diagnostic strategy for MSKIs (i.e., routine use of invasive
procedures versus blood culture alone). The Pediatric Health Information System (PHIS) database contains
administrative data from millions of inpatient encounters and could be leveraged to efficiently study the diag-
nostic variability for MSKIs at 52 pediatric hospitals in the United States. In addition, new diagnostic modalities
have emerged that hold promise for pediatric MSKIs but need further study in these patients. Specifically, next-
generation sequencing of microbial cell-free DNA (mcfDNA) from a peripheral blood specimen is a newly de-
veloped non-invasive diagnostic test that uses a “liquid biopsy” to detect more than 1000 potential pathogens.
Although mcfDNA testing is approved for clinical use, this test has not been validated in children with MSKIs
specifically. The lack of evidence for how mcfDNA compares to invasive diagnostic procedures limits its clinical
utility in this population. The Infectious Diseases Society of America (IDSA) recently called for new studies to
determine whether mcfDNA testing could improve care for pediatric MSKIs. In addition, mcfDNA has an esti-
mated cost of more than $2000, and cost analyses are needed to justify its use. This proposal aims to address
the critical need for an optimized diagnostic strategy in pediatric MSKIs by (1) describing national variability in
diagnostic testing and associated clinical outcomes for acute pediatric MSKIs; (2) determining the clinical
performance of non-invasive mcfDNA testing for MSKIs compared to microbiological testing of surgically
collected bone and joint specimens; (3) describe the cost of mcfDNA as compared to existing diagnostic
options for pediatric MSKIs. This project is the culmination of this candidate’s dedication to improving clinical
outcomes for children hospitalized with MSKIs. The objective of this award is for the candidate to develop the
skills needed to meet his long-term goal of becoming an independent investigator studying diagnostic
innovation for pediatric infections. The candidate will build on his research skillset through expert mentorship,
didactic coursework, and experiential training in diagnostic trials and descriptive cost analyses. The candidate
has thoughtfully assembled a multidisciplinary mentorship team with extensive expertise in the above aims to
help him successfully complete his career training goals and research specific aims.

Public health relevance
PROJECT NARRATIVE: This proposal aims to optimize the diagnostic strategy for pediatric musculoskeletal infections (MSKIs). The proposed research will leverage a national database of pediatric hospitals to describe the variable diagnostic approaches and associated clinical outcomes for MSKIs amongst children’s hospitals in the United States and will evaluate the clinical performance and comparative cost of a non-invasive diagnostic strategy for pediatric MSKIs.